PEDIATRIC HEALTH SERVICES RESEARCH TRAINING

DESCRIPTION (Adapted from applicant's description): The goal of this training program is to recruit academically promising men and women into careers in pediatric health services research, and to challenge them to address key substantive and methodologic problems in the field. This will be done by providing trainees with the conceptual and analytic skills required to address a broad range of health services research issues through collaboration among organizational and administrative resources at The University of Michigan, based primarily in the Schools of Medicine and Public Health. To achieve its goals, the program aims to: a) provide students with a sound academic background, research training, and socialization in health services and health services research; b) recruit and provide financial support to scholars with a strong commitment to pediatric health services research; and c) stimulate interest and interaction among students, fellows, faculty, and researchers concerned with issues of pediatric health services. The program will sponsor two-year traineeships for post-doctoral fellows. Trainees will enter the program having completed their residency training; some may have additional training in research. The traineeship experience will include: course work in health services concepts and issues, as well as health services research methods; active involvement in ongoing research programs; participation in research seminars and professional conferences; and structured interchanges across disciplines and occupations. The training experience will provide trainees with rigorous health services research training, knowledge of special issues of contemporary health services research, and a specific research program to guide their future work. As a result of this training, trainees will be able to integrate their medical training with health services content and methods.